NRSA Training Core

Contact PD/PI: FITZGERALD, GARRET A NRSA-Training-001 (532)
TL1 Abstract: NRSA Training Core
The purpose of the Penn NRSA Training Core is to enhance training in clinical translational science (CTS) to
expedite the translation of scientific discovery into therapy and improve the quality of patient care. The mission
of our TL1 program is to (i) recruit and train a next generation of CTS investigators who are equipped with the
awareness, knowledge and skills necessary to successfully translate discoveries into clinical care, and (ii) to
prepare them for a range of research careers. Penn’s TL1 program is designed to attract, train and support a
diverse cohort of predoctoral trainees from graduate research programs (PhD, MD/PhD, VMD/PhD) and clinical
training programs (MD, VMD, DMD) as well as postdoctoral research scientists (PhD) and clinicians (MD, VMD,
DMD). Appointees enter their CTS training from various educational trajectories and with diverse expectations
and career aspirations; for this reason the Penn TL1 is flexible and inclusive of cross-disciplinary coursework
and/or completion of a graduate-level certificate or Master’s degree. Appointment durations vary between one
year for predoctoral appointees and either one or 2-3 years for postdoctoral appointees. Predoctoral trainees will
complete the TL1 with a solid understanding of the discipline and core competencies for performing CTS
research. Postdoctoral trainees will have demonstrated CTS research independence in the form of publication
in peer-reviewed literature, appointment to a mentored career development award or other independent grant
funding and an academic or industry appointment with continued substantial engagement in CTS. Coupled with
a dedicated mentoring program and a robust diversity and inclusion effort, the objectives of the TL1 program are
based on the following:
1. (i) Continue to provide a comprehensive curriculum in discovery-, entrepreneurial-, and regulatory science,
translational therapeutics, and biomedical informatics; (ii) expand coursework to include data- and
implementation science, investigational pharmacy, and health care innovation; and (iii) continue to increase the
awareness of CTS training opportunities to recruit high caliber trainees.
2. (i) Continue development efforts on professional skills training, and (ii) add programs to support postdoctoral
trainees at points of transition and prepare postdoctoral PhDs for diverse career paths.
3. Develop skills-based workshops and labs for all TL1 trainees that are responsive to real-time innovations in
science, shifting health priorities and rapidly evolving learner needs.
4. Expand opportunities for pre- and postdoctoral trainees to immerse themselves in projects at the academic-
industry interface through the creation of shared training programs so that they may partake in real-world
scenarios of innovation being reduced to practice.
Project Summary/Abstract Page 1246
Contact PD/PI: FITZGERALD, GARRET A NRSA-Training-001 (532)
OMB Number: 4040-0010
Expiration Date: 12/31/2022
RESEARCH & RELATED Senior/Key Person Profile (Expanded)
PROFILE - Project Director/Principal Investigator
Prefix: First Name*: Emma Middle Name Anne Last Name*: Meagher Suffix:
Position/Title*: Senior Associate Dean for Clinical Res
Organization Name*: University of Pennsylvania
Department:
Division:
Street1*: ITMAT - Perelman School of Medicine
Street2: 3400 Spruce Street
City*: PHILADELPHIA
County:
State*: PA: Pennsylvania
Province:
Country*: USA: UNITED STATES
Zip / Postal Code*: 191040000
Phone Number*: 215-662-2174 Fax Number:
E-Mail*: [email]
Credential, e.g., agency login: emeagher
Project Role*: Other (Specify) Other Project Role Category: Project Lead
Degree Type: MD Degree Year: 1987
Attach Biographical Sketch*: File Name:
Attach Current & Pending Support: File Name:
Page 1247
Tracking Number: GRANT13073932 Funding Opportunity Number: PAR-18-940 . Received Date:
2020-04-16T15:07:17.000-04:00